EFFECTS OF MORPHINE ON IDENTIFIED CNS PEPTIDERGIC NEURON

The effects of morphine upon several neuroendocrine functions of the brain will be studied in this proposal. Five neuropeptide systems have been chosen; these are (1) the beta-endorphin (POMC) neurons (crucial to the central effects of morphine), (2) the alpha MSH-specific system, (3) vasopressin (AVP, (4) corticotropin releasing factor (CRF), and (5) thyrotropin releasing factor (TRF). A newly developed isolation technique will be used to prepare cultures of pure populations of POMC, AVP, and CRF neurons from the hypothalami of normal and morphine-treated animals. Beta-endorphin (POMC) neurons will be studied in detail with respect to: (1) early post-translational processing, and upon acetylation of POMC peptides, particularly beta-endorphin and alpha-MSH, (2) interactions with TRF which may be an endogenous antagonist, (3) gastric, which may coexist in the POMC neuron, and (4) their (opiate) pre- and postsynaptic receptors.